Moving Beyond the Individual- A Data-driven Approach to Improving the Evidence on the Role of Community and Societal Determinants of HIV among Adolescent Girls and Young Women in Sub-Saharan Africa

PROJECT SUMMARY/ABSTRACT
Adolescent girls and young women (AGYW) in sub-Saharan Africa (SSA), the epicenter of the global HIV
epidemic, have carried the primary burden of new HIV infections in this area for at least 30 years. Research
has prioritized characterizing the individual predictors of HIV infection among AGYW by creating risk
assessment tools that identify high-risk sub-populations for targeted HIV prevention efforts. Despite substantial
efforts, there remains a disproportionate burden of disease among this vulnerable population, suggesting a
need to identify and assess targets of intervention beyond the individual. The primary goals of this R36
dissertation proposal, Moving Beyond the Individual: A Data-driven Approach to Informing the Evidence on the
Role of Community and Societal Determinants of HIV among Adolescent Girls and Young Women in Sub-
Saharan Africa, are to create a comprehensive data source that will facilitate new ways of assessing HIV risk
among AGYW, generating improved knowledge about individual, interpersonal, community, and societal risk
factors; to characterize the interplay among these variables; and to assess the impact of interventions that
target community and societal drivers of infection to inform improved prevention efforts. To achieve these
goals, we propose three aims that will leverage publicly available, population-based data from five countries in
SSA (Cameroon, Eswatini, Malawi, Rwanda, and Uganda) and apply advanced data science and
epidemiologic methodologies. Aim 1 is to integrate publicly available data from the Population-based HIV
Impact Assessment Project (individual, interpersonal, community), the Population and Housing Census
(community), and UNAIDS Law and Policy Indicators (societal) to create a large, multi-level public health
dataset. Aim 2 is to characterize and graphically depict the pathways among individual, interpersonal,
community, and societal risk factors of HIV infection among AGYW using causal discovery algorithms to
identify underlying disease pathways. Aim 3 is to estimate the impact of intervening on community and societal
drivers of HIV infection among AGYW using parametric g-computation to model proposed intervention effects.
To examine these aims, we will take a novel, intersectional approach to assess HIV behavioral science
inquiries by leveraging causal discovery algorithms and g-computation. Findings from this research will
advance the National Institute of Mental Health Division of AIDS Research’s priority to improve the knowledge
base informing interventions, thereby advancing the development of interventions that go beyond the individual
to reduce the burden of HIV among AGYW. The research and mentorship of this R36 proposal have been
carefully crafted to optimize the ongoing doctoral training and research experience of the Principal Investigator
of this study while fostering her development as an African American independent research scientist in the
future.

Public health relevance
PROJECT NARRATIVE This dissertation proposal highlights the continuing burden of HIV that affects adolescent girls and young women in sub-Saharan Africa. Although individual behaviors and attitudes are influenced by many interpersonal, community, and societal factors, HIV prevention research has focused on the individual as the risk-taker and therefore, the primary target for HIV prevention interventions. This study will go beyond the individual to inform the development of community and societal HIV prevention approaches and model interventions that promise the most benefit to adolescent girls and young women.